The development of the trade-off between sampling and remembering the visual world

ABSTRACT
Imagine baking a croquembouche, a new culinary challenge. How many steps ahead in the recipe will you bother
to remember? Of course, you can always refer back to the recipe itself, so you needn’t remember much.
Everyday tasks involve strategic trade-offs between sampling (utilizing the external resources provided by stable
objects and symbols in the visual world) versus remembering (utilizing the internal resources of working
memory). Here our goal is to answer the question: When it’s up to you, how much will you remember?
Historically, working memory has been measured under ideal conditions – well-informed, motivated
participants doing simple tasks – to isolate best-case performance. Estimates of WM from these types of studies,
however, provide a challenge for generalization: real-world conditions are not ideal and performance is rarely
best-case. Our view, captured by our dynamic feedback model, is that an individual trades off sampling versus
remembering in order to strike a preferred balance between the subjective costs of using external
resources (the overhead of having to refer to information in the environment) with the subjective costs of
using internal resources (the cognitive effort required to maintain task-relevant information in WM).
Nearly all of the previous empirical work investigating the sampling-remembering trade-off has been with
adults. This leaves a tremendous gap in our understanding since the optimal use of internal resources such as
WM is even more crucial when those resources are more limited, as in children. We developed an innovative
“Shopping Game”, a child-friendly, tablet-based paradigm where children are shown a shopping list, then
asked to select those items from a virtual store. Since the list is long, and the list and store are not visible at the
same time, the child must toggle back and forth between the two. Through the parametric variation of time delays
to access the store or the list, we will independently manipulate the subjective costs to use those internal and
external resources, and through pupillometry, we will track moment-to-moment cognitive effort deployment.
Importantly, we propose to study these mechanisms in a large longitudinal study of 6-7-year-old children,
during a period right after school entry, when children are first faced with cognitive tasks that require
memorization. Children’s steadily increasing WM capacity during this period provides a unique opportunity to
test predictions of our model that could not be tested in adults.
Combining psychophysics, pupillometry, and standardized cognitive assessments, we will conduct a
critical multi-method, naturalistic test of how the cognitive control mechanisms of working memory use develop.
Our project will provide (1) the first model-based analysis of the sampling-remembering trade-off and (2)
the first direct, longitudinal study of the deployment of cognitive effort in children.

Public health relevance
NARRATIVE Combining behavioral and neurophysiological methods, we propose to investigate the development of the strategic use of working memory resources in children during a period right after school entry (from 6 to 7 years of age, longitudinally) when children are first formally faced with cognitive tasks that require memorization. Understanding strategic working memory use in children has important potential implications for educational psychology. Our paradigm is also well suited for systematic comparisons between typically and atypically developing children (e.g. those diagnosed with ADHD).